An efficient, exposure-based treatment for PTSD compared to Prolonged Exposure: A non-inferiority randomized trial

Although Written Exposure Therapy (WET) is listed in the upcoming VA/DoD PTSD Practice
Guidelines as an evidence-based, recommended PTSD treatment, there are limited data
supporting the use of WET with veterans suffering from PTSD. Additional research is needed to
support the use of WET for the treatment of veterans diagnosed with PTSD. The goal of this
study is to investigate whether WET is non-inferior in the treatment of PTSD in a sample of
veterans diagnosed with PTSD. Men and women veterans diagnosed with PTSD will be
randomly assigned to either WET (n = 75) or Prolonged Exposure (PE; n = 75). PTSD symptom
severity will serve as the primary outcome. Assessments will be conducted by independent
evaluators at baseline, 10-, 20-, and 20-week post first treatment session. WET is expected to
be non-inferior to PE in reducing PTSD symptom severity. In addition, WET is expected to have
significantly lower treatment dropout rate relative to the first five sessions of PE (i.e., better
treatment engagement). Moderators of treatment outcome for both treatment conditions will
also be investigated. If WET is found to be non-inferior to the more time intensive PE treatment
then the VA will have evidence to support the use of a brief PTSD treatment, which will assist in
addressing the high demand for PTSD clinical services.

Public health relevance
PTSD is a prevalent condition for which veterans frequently seek treatment in the VA healthcare system. Although there are several first-line PTSD treatments available, at least one third of veterans drop out prematurely from these treatments. Further, VA mental health treatment providers have noted numerous systemic barriers to implementing these treatments with their veteran clients. These problems underscore the need to identify alternative, evidence-based treatments that address both patient and provider concerns. Written Exposure Therapy (WET) may be such a treatment. If WET is found efficaciously treat veterans with PTSD, then VA would have a brief and well-tolerated PTSD treatment option for use with veterans.